Administrative Core

An efficient administrative structure is essentia! to the design and implementation of this U19 Program. The Administrative Core is designed to facilitate communication, planning, data sharing, and scientific and fiscal oversight of the component research projects of the Program. Through Core A, the Core Director will oversee all the goals of this research Program. The Core Director will serve as the primary contact between project investigators, and will serve as the liaison between this research group and the NIH program staff. The Core will facilitate the Program's compliance with NIH and institutional policies, grants management, and will fund yearly travel of the Program investigators to Bethesda and Seattle for the annual extemai and internal review of the Program, respectively. The Core will include a Project Manager who will coordinate, schedule, and implement minimum monthly internal meetings and teleconferencing among the Program sites, and will prepare progress reports, internal compliance filings and edit manuscripts to support the Program. The Core will oversee data sharing, data archiving, and overall record keeping of the Program.

Public health relevance
The Administrative Core will play an important role to facilitate the scientific and fiscal management ofthe U19 research Program. The Program is focused on defining the virus-host interactions that control innate immunity against Hepatitis C virus (HCV). This work is important because HCV infects nearly 200 million people across the globe and is thus a major public health threat. The Administrative Core will serve the Program to mediate efficient communication and scientific discussion between the Project investigators and the NIH staff to support our goal of improving the outcome of HCV infection and antiviral therapy.